Novel Formulation Technology to Enhance Oral Absorption of Water-insoluble Drugs

Abstract
No changes will be made to the proposed supplement activities.

Public health relevance
Project Narrative No changes will be made to the proposed supplement activities.